Elucidating the role of type 2 conventional dendritic cells in shaping anti-tumor immunity

Project Summary
Immunotherapies that stimulate the immune system to kill tumors have revolutionized cancer treatment. Many
immunotherapies in the clinic directly target cytotoxic CD8 T cells to reinvigorate their functional capacity and
to kill tumors. However, such treatments have low objective response rates and therefore, it is imperative to
utilize novel strategies that work synergistically to boost protection from these immunotherapies. Conventional
dendritic cells (cDCs) are an ideal target as these antigen presenting cells play a critical role in regulating anti-
tumor immunity by shaping the magnitude and character of anti-tumor T cell responses. cDCs are
heterogenous and consist of two unique subsets, type 1 cDCs (cDC1) and type 2 cDCs (cDC2). cDC1s are
well studied in cancer due to their ability to initiate and regulate CD8 T cell responses and correlate with
increased responses to anti-PD-1 immune checkpoint blockade immunotherapy. The role for cDC2s in shaping
anti-tumor immunity are less clear, but cDC2s have been associated with worse patient prognosis in metastatic
melanoma patients. cDC2s are classically thought to regulate CD4 T cell responses, however, we and others
have shown that cDC2s have the capacity to regulate CD8 T cell responses as well. Due to the availability of
tools and their protective nature, cDC1s have been most studied in cancer. However, I have found that cDC2s
induce unique CD8 T cell phenotypes in ex vivo studies and correlate with increased CD8 T cell exhaustion in
metastatic melanoma. In this project, I will test the hypothesis that intratumoral cDC2s limit anti-tumor immunity
by promoting CD8 T cell exhaustion. I will test this by utilizing ex vivo co-cultures to understand the
mechanisms by which cDC1s and cDC2s differentially regulate CD8 T cell phenotype (Aim 1) and by
characterizing the co-localization of cDC subsets and exhausted CD8 T cells in human melanoma with spatial
transcriptomics and fluorescent multiplex immunohistochemistry (Aim 2). The proposed research will address
major knowledge gaps regarding how different cDC subsets regulate anti-tumor CD8 T cells within the tumor
microenvironment and will contribute to the development of novel immunotherapies that will work in concert
with current treatment options to boost anti-tumor immunity.

Public health relevance
Project Narrative Cancer affects millions of people worldwide and treatment options that leverage the immune system have only been effective in a subset of patients. Conventional dendritic cells (cDCs) are innate immune cells that play an essential role in regulating cytotoxic CD8 T cell responses. The goal of this project is to define the mechanisms by which cDC subsets regulate CD8 T cell responses within the tumor microenvironment that can be applied to develop novel treatment strategies to boost the anti-tumor immune response.